Interdisciplinary Training in Alcohol Research

Abstract
This competing continuation application seeks an additional five years of support for a pre-doctoral
interdisciplinary training program in research on alcohol and alcohol use disorders. The training program, led
by co-directors Drs. Fillmore and Prendergast, is based in the Psychology Department at the University of
Kentucky but includes preceptors from five departments and two colleges across the UK campus. The program
provides graduate students with interdisciplinary training to effectively investigate and discover the intricacies
and complexities of alcohol use disorders, at all levels of investigation from the cellular and neurophysiological
systems to the roles of personality, social and environmental factors. The need for a translational and
interdisciplinary program in the investigation of alcohol use disorders is great as advancements and
discoveries continue to be made across multiple levels of investigation. This core expertise among our training
faculty allows us to deliver a true interdisciplinary laboratory training experience on alcohol use disorders, not
readily available, or duplicated elsewhere. The first period of this T32 award witnessed impressive
accomplishments by our trainees as indicated by their publications, scholarly awards including F31s, and post-
doctoral placements in research and clinical centers specializing in alcohol use disorders. This continuation
application seeks to build on that success during the next award period.

Public health relevance
The purpose of this renewal application is to continue a translational and interdisciplinary training program in alcohol research. This multidisciplinary program provides training in bio-behavioral factors associated within alcohol-use disorders at the pre-doctoral level; graduates of this program are actively involved in research, teaching, publishing articles, and becoming independent researchers in the alcohol field. We aim to advance our program of excellence in translational or interdisciplinary research training because the need for a translational or interdisciplinary program is greater today than ever before, and the proposed continuation of this training program fills a unique niche in alcohol research.